MUSCARINIC MECHANISMS OF NEUROCARDIOVASCULAR CONTROL--STUDIES OF XANOMELINE

Establish whether xanomeline, a novel, centrally-active muscarinic M1 agonist, alters cardiovascular control and/or orthostatic tolerance.